Trajectories of blood-based biomarkers of AD, their determinants, and ability to predict cognitive impairment

The AT(N) framework uses PET and/or CSF biomarkers to define Alzheimer’s Disease (AD)
pathology and continuum; however, its broad implementation is restricted by high cost and
limited accessibility. Recent advances in primarily Caucasian samples have identified plasma
AD biomarkers – namely, the ratio of Aβ42/Aβ40 and phosphorylated tau (p-tau, e.g. p-tau181,
p-tau217) – that are highly sensitive and specific for detecting abnormal Aβ and Tau. Plasma p-
tau is particularly promising for AD diagnosis and prediction of conversion to AD; yet, their
potential as markers of disease progression and risk predictors for mild cognitive impairment
(MCI)/AD, especially among racial/ethnic minorities who are disproportionately affected by AD,
remains largely unexplored. Here, our objective is to use trajectories of promising plasma AD
biomarkers to 1) define their natural history, 2) their ability to predict the risk of developing AD-
specific cognitive impairment, and 3) to identify their molecular determinants. We propose to
measure Aβ42/Aβ40 and p-tau217 in 3,810 MESA participants, across five time points (Exam 1,
4, 5, 6 & 7) spanning 22 years, and human neuronal cell lines to achieve the following specific
aims: Aim 1. To quantify two plasma AD biomarkers (p-tau217 and Aβ42/Aβ40) and determine
their changes with age starting from age 45 to 100+. Aim 2. To determine the ability of baseline
and longitudinal changes in plasma AD biomarkers to predict future cognitive impairment. Aim
3. To examine effects of vascular aging and cognitive decline-associated genomic features, that
we have previously identified, on AD biomarkers. The proposed MESA longitudinal study
combining plasma AD biomarkers with multi-omics data, cardiometabolic measures, brain
imaging, cognitive testing, and clinical MCI/AD data across the mid- to late-life transition period
is a critical next step to evaluate the utility of plasma AD biomarkers to predict future risk of
cognitive impairment in a racially and ethnically diverse population, and to identify candidate
causal molecular processes in early AD pathogenesis that could serve as targets for disease-
modifying interventions.

Public health relevance
Project Narrative Plasma AD biomarkers recently emerged as having promising value for detecting abnormal AD pathology. The proposed study will investigate the trajectories and predictive power of plasma AD biomarkers, namely p-Tau and amyloid beta, for future cognitive impairment, and their molecular determinants, in a community-based cohort of dementia free individuals from racially/ethnically diverse populations.